Sex-specific Influences on tear microRNAs in dry eye disease

PROJECT SUMMARY
Dry eye disease (DED) affects millions of Americans, causing discomfort, vision problems, pain, and potential
ocular surface damage. The prevalence of DED is higher in women than men, and there may be molecular
differences among racial groups. Tear fluid, which can be collected non-invasively, holds promise for
identifying DED biomarkers. Our hypothesis is that the molecular composition of tear fluid can distinguish DED
subtypes and correlate with clinical signs and severity. MicroRNAs (miRNAs) in circulation have shown great
stability and resistance to degradation over long-term storage. Therefore, miRNAs present in tear fluid hold
significant promise for clinical biomarkers, complementing proteins.
In this proposal, we aim to analyze a large sample set (n=800) to discover sex- and race-specific differences in
tear miRNAs and proteins and their relationship to disease severity and subtypes. By considering diverse
populations, confounding factors, and integrating multi-omics data, we will identify reliable biomarkers
applicable in clinical settings. We anticipate that discovering tear biomarkers will improve DED diagnosis and
enable personalized treatment based on each patient's tear composition. Personalized medicine approaches
accounting for sex and race-specific factors will guide tailored treatments, improving outcomes for DED
patients.
Furthermore, we will explore the interplay between tear miRNAs and proteins, investigating potential
connections and novel molecular mechanisms. Machine learning will be employed to deepen our
understanding of the underlying molecular processes involved in DED subtypes and provide insights into
therapeutic targets and interventions.
Finally, we will create a reference database compiling a comprehensive profile of miRNAs and proteins
detected in human tear fluid. This freely accessible database will include demographic parameters, clinical
histories, and functional tools for data analysis and visualization. It will serve as a valuable resource for vision
researchers studying the expression patterns of molecules of interest in human tears, facilitating further
investigations and advancements in the field.

Public health relevance
PROJECT NARRATIVE Dry eye disease (DED) disproportionately affects females and displays variations among different racial backgrounds. The purpose of this proposal is to investigate the sex- and race-specific disparities in tear miRNAs and proteins, and their correlation with established DED subtypes and severity. Additionally, we will establish a comprehensive database that compiles the miRNAs and proteins detected in human tear fluid, providing a valuable resource to the scientific community.